Investigating the mechanisms of reduced neuron generation in Down Syndrome

PROJECT SUMMARY
Down syndrome (DS, trisomy 21, T21), the most common genetic cause of intellectual disability, is
characterized by reduction in cortical size and neuron number. The fundamental question of how an extra copy
of human chromosome 21 (HSA21) causes reduced brain growth and neuron formation remains unanswered.
Extensive literature supports that fewer neurons are apparent at and before birth, suggesting impaired
neurogenesis is a key cellular mechanism in DS. A highly controlled balance between neural progenitors and
their differentiated, post-mitotic neuron counterparts is critical to generating the highly complex human neocortex,
particularly the superficial cortex which is believed to contribute to human-specific higher order intelligence.
Limited analysis of human DS tissue and neural progenitors generated from T21 disorder specific induced
pluripotent stem cells (iPSCs) support that fewer progenitors populate the developing DS cortex. However, it
remains unclear whether the reduction in progenitors is due to prolonged cell cycle, early differentiation into
neurons, progenitor cell death, or a combination of some/all of these mechanisms.
To date, an incomplete understanding of the seemingly basic, but important, neural progenitor cell (NPC)
behavior during neurogenesis has prevented the unbiased, developmentally grounded, study of upstream sub-
cellular and molecular signals that drive reduced neurogenesis in T21. My previously published work in the
Bhattacharyya lab shows global transcriptional changes in early NPCs and specifically implicates WNT signaling
and mitochondrial dynamics. Both of these pathways have broad developmental significance, particularly when
it comes to regulating progenitor proliferation, apoptosis and differentiation into neurons.
The goals of this F30 pre-doctoral fellowship are to (1) evaluate the contribution of cell death, prolonged
cell cycle length, and early differentiation to reduced progenitor pools in T21 and (2) leverage unbiased data in
this critical period to define and test mechanistic pathways that cause reduced neurogenesis in T21. This F30
proposal will be the first study of produce a detailed assessment of T21 NPC cell cycle length and progression
as well as exciting data regarding mitochondrial dynamics across this key transition from NPC to neuron in T21.
The results from this project will meet the goals of the NIH INCLUDE project by establishing scientific data critical
to understanding early DS pathology and improving neurodevelopmental outcomes in individuals with Down
syndrome.

Public health relevance
RESEARCH NARRATIVE Individuals with Down syndrome (DS, T21) have reduced cortical volume, fewer neurons and smaller progenitor pools but how the extra copy of human chromosome 21 (HSA21) causes these features remains unanswered. Proper expansion of neural progenitor cells (NPCs) is crucial to generating the appropriate number of neurons, so I hypothesize that increased NPC death, prolonged cell cycle length, and/or early cell cycle exit contribute to reduced progenitor pools in T21. The project in this fellowship will test the contribution of these three non-exclusive mechanisms to reduced progenitor pools in T21 and identify upstream molecular and cellular pathways to provide mechanistic insight into the impact of T21 on neurogenesis.